Biomarkers of Cognitive Decline Among Normal Individuals: The Biocard Cohort

OVERALL – PROJECT SUMMARY/ABSTRACT
This is a competing continuation for a grant entitled ‘Biomarkers of Cognitive Decline Among Normal
Individuals: The BIOCARD Cohort’ (FOA: PAR-18-296). This study, known as the BIOCARD study, is a
longitudinal, observational study of 349 individuals who were cognitively normal and primarily middle aged
(mean age=57.1) at enrollment. By design, two-thirds had a family history of Alzheimer’s disease (AD). The
primary goal was to follow individuals from normal cognition to mild cognitive impairment (MCI) or dementia, so
that it would be possible to identify biomarkers that predicted progression. The BIOCARD study is in a unique
position to examine the ‘preclinical’ phase of AD, since the participants: (1) have been followed for up to 27
years (mean follow-up = 15.2 yrs.), (2) are continuing through the period of accelerating risk, and (3) 64 of
those alive have MCI or dementia. Our overall objectives are to further advance the study of preclinical
AD by: (1) clarifying the pattern and rate of change in AD biomarkers (including those based on CSF, blood,
MRI, and PET imaging) and cognition; the biomarkers to be studied include several promising novel
biomarkers derived from blood, CSF and brain imaging. (2) maximizing our data by working collaboratively with
several research groups who have comparable data, and (3) providing a publicly accessible data, brain scans,
and biological specimens, for researchers in the field. The long duration of follow-up for the cohort is based on
the fact that the study was established in 1995 by investigators in the intramural program of the NIH. The study
was stopped for administrative purposes in 2005. Our investigative team was funded in July 2009 to re-enroll
the participants and re-initiate longitudinal data collection. Longitudinal follow-up was continued with our grant
renewal in 2014. With this application, we are requesting funds to continue the longitudinal assessments which
include: clinical and cognitive assessments, CSF, blood, MRI scans, and amyloid PET (using [11-C] PiB) and
to initiate Tau PET (using [18 F] MK-6240), in the participants who remain cognitively normal (n=198, mean
age = 70.9). We are also proposing to recruit an additional 150 subjects to increase the diversity of the
participants and to expand the number of middle age subjects who can be followed with state-of-art-
techniques. The rich data to be acquired will provide continued insights into the preclinical phase of AD.

Public health relevance
OVERALL – PROJECT NARRATIVE The overarching goal of this research is to improve our understanding of the earliest stages at which Alzheimer’s disease develops. In this study we are examining a range of biomarkers that may help identify those who are cognitively normal but at high risk of developing cognitive decline. It is hoped that this will lead to a better understanding of the disease and to effective interventions that may prevent progression.